IFN/SOCS1 signaling during post-influenza bacterial infection

PROJECT SUMMARY
Influenza and influenza-complicated pneumonia cause up to 50,000 deaths annually in the United States despite
the availability of vaccines and antiviral drugs. Although influenza A virus (IAV) infection alone can cause
pneumonia, secondary infection by Streptococcus pneumoniae leads to excess morbidity and mortality. IAV
infection induces peak type I IFN (IFN-I, i.e., IFNα/β) and IFN-γ production at the innate and adaptive phase of
infection, respectively. IFN-I signaling promotes monocyte recruitment but inhibits neutrophil recruitment after
IAV infection. Accordingly, IFN-I has been shown to suppress neutrophil-mediated bacterial control. Supporting
data in this application show that IFN-I plays a dual role in IAV/S. pneumoniae coinfection by inhibiting initial
bacterial killing while also preventing a detrimental IFN-γ response. Suppressor Of Cytokine Signaling 1 (SOCS1)
is a feedback inhibitor of the IFN/STAT1 signaling pathway. Novel data indicate that SOCS1 exacerbates
antibacterial complications during acute IAV infection and prolongs host susceptibility to invasive S. pneumoniae
infection after viral clearance. However, the mechanism by which SOCS1 promotes IAV/S. pneumoniae co-
pathogenesis remains to be established.
Resident alveolar macrophages are essential and normally sufficient for clearance of a physiologically
relevant dose of S. pneumoniae. As airway sentinel cells, alveolar macrophages also produce acute
inflammatory cytokines to recruit neutrophils for additional bacterial killing. However, these antibacterial functions
of alveolar macrophages, including phagocytosis and innate signaling, are suppressed after IAV infection.
Monocytes recruited during acute IAV infection increase lung damage and promote host susceptibility to
pneumococcal pneumonia. Conversely, after viral clearance, these CCR2-recruited monocytes can differentiate
into alveolar macrophages to confer antibacterial protection. It remains unclear how this alveolar macrophage
replenishment mechanism is orchestrated during resolution of IAV infection, but novel data in the application
suggest that SOCS1 inhibits alveolar macrophage restoration after viral clearance. Thus, the central hypothesis
of this application is that IFN/SOCS1 signaling in IAV infection inhibits alveolar macrophage-dependent
antibacterial protection, thereby predisposing the host to secondary pneumococcal pneumonia. This hypothesis
will be tested in three specific aims: 1) define how differential effector cells contribute to the paradoxical role of
IFN-I, 2) determine how SOCS1 contributes to the synergistic suppression of antibacterial immunity by IFN-I and
IFN-γ, and 3) establish how SOCS1 regulates monocyte differentiation and alveolar macrophage restoration after
viral clearance. Given that IFN/SOCS1 signaling is a characteristic feature of acute viral infection, identifying
how this axis renders hosts unable to control opportunistic bacteria will provide novel understanding of immune
complications associated with invasive bacterial pneumonia.

Public health relevance
PROJECT NARRATIVE A frequent sequela of influenza infection is secondary bacterial pneumonia. Even with currently available antibiotics, bacterial pneumonia is a major cause of morbidity and mortality in influenza pandemics and epidemics. The objective of this study is to identify key host factors responsible for this influenza-induced complication, and thereby provide the basis for developing therapeutics for these infectious diseases in humans.